The role of macrophages in neonatal nociceptive priming

Project Summary/Abstract: Early life insults have the ability to “prime” the somatosensory system (neonatal
priming) which changes the way peripheral stimuli are perceived. This can lead to worse outcomes after an
injury later in life. As a result, significant clinical problems such as chronic pain and increased opioid use can
occur. A better understanding of how acute neonatal injury facilitates the transition to chronic pain later in life is
therefore crucial. Previous work has begun to dissect the central neuronal and immune components that
contribute to neonatal nociceptive priming, but the peripheral component is vastly understudied. It is known
however that a peripheral input is required for the “priming” effect to be induced and more recent data suggests
that immune cells are necessary for altering nociception uniquely in neonates compared to older subjects. Our
preliminary work confirms recent literature that neonates in which macrophages are ablated, do not
demonstrate injury-induced mechanical hypersensitivity. Interestingly, macrophages are also unique in
neonates as they have the ability to retain epigenetic modifications from early life stimulation. This epigenetic
vulnerability in immature macrophages may provide a mechanism that drives neonatal nociceptive priming.
This project will aim to answer the major gaps in the literature by providing a better understanding of how the
peripheral immune system retains a memory of early life injury to effect nociception later in life. We will test
the central hypothesis that the activation of neonatal macrophages following acute injury alters their
epigenetic regulation of neuroimmune signals which is critical for the development of neonatal
priming. We will test this through a series of experiments that interrogate the necessity of macrophages
through knockout strategies, sufficiency of macrophages through adoptive transfer, and determine epigenetic
mechanisms within macrophages that may underlie this phenomenon. Specific Aim 1 uses our ex vivo
electrophysiological recording preparations, assays of behavioral sensitivity, and measures of inflammation in
mice with depletion (MaFIA mice) or adoptive transfer of macrophages to determine the effects of neonatal
incision on peripheral sensitization and nociceptive priming. Specific Aim 2 first uses unbiased sequencing
strategies in macrophages, and then evaluates whether macrophage specific expression of the
developmentally regulated histone deacytalase, SIRT1, modulates neonatal nociceptive priming. In order to
address these questions, a team of researcher mentors have been assembled to provide expertise in sensory
neuroscience and neonatal nociception (Dr. Jankowski, primary sponsor), immunology (Dr. Deepe, co-
sponsor) and epigenetics (Dr. Kottyan, co-sponsor) who will instruct and help me with these specific research
studies. This team of mentors will also provide all of the necessary academic and scientific development to
further my career in the neurosciences. Collectively, this project will provide impactful information on neonatal
priming and allow me to establish a solid foundation for an independent career in pain biology.

Public health relevance
Project Narrative The proposed research is relevant to public health as it explores some of the mechanisms that underlie difficulties managing pediatric pain and the formation of chronic pain. This innovative proposal will determine potential underlying mechanisms that results in differences between neonatal and older animal, and the necessity and sufficiency of the peripheral immune system in injury and re-injury to determine a cause of chronic pain after re-injury. Thus, the proposed research is relevant to the NIH’s Federal Pain Research Strategy, which identified understanding mechanisms of childhood pain as one of their top priorities.